Gut extracellular vesicles promote alcohol-induced liver injury via TLR4-regulated miRNAs

The overarching theme of this supplementary project is to add the new information of parent award that nutrition lead to the changes of extracellular vesicles (EVs) of IECs in alcoholic liver disease (ALD). We will focus on ω6 PUFAs and gut microbiota-regulated exmiRNAs. Specifically, we will examine how ω6 PUFAs stimulate the production of gut EVs through TLR4/STAT3 signaling and the consequences of these events in the development of ALD via gut-liver axis. Novel in vitro and in vivo approaches will be used to address mechanisms of action with the goal of identifying new targets for intervention. We propose that ω6 PUFAs induce the dysbiosis of gut microbiota, which contribute to the changes in the miRNAs profile of gut-derived EVs. We specifically propose that TLR4/STAT3-activated extracelluar miRNAs production is the key to the activation of macrophages during ω6 PUFAs-induced chronic inflammation in ALD. Based on our published work and other preliminary data, this proposal will test the hypothesis that ω6 PUFAs regulate the production of gut extracellular miRNAs through TLR4/STAT3 signaling, which initiates a crosstalk among macrophages and hepatocytes in ALD. Moreover, we will determine whether supplement of ω3 PUFAs with diet-associated nanoparticles carrying inflammatory miRNAs inhibitor have potential therapeutic implications in ALD. These hypotheses will be tested in the following Specific Aims: Aim 1: Determine the role of ω6 PUFAs-regulated gut EVs in alcohol-induced liver inflammation. Aim 2: Determine whether alteration of IEC miRNAs via TLR4/STAT3 modulation affects the severity of ω6 PUFAs-induced liver inflammation and injury in ALD. .

Public health relevance
Project Narrative This proposal underscores the importance of investigating n-6 PUFAs-activated extracellular miRNAs as a critical IECs-derived factor for the development of alcoholic liver diseases by regulating the function of hepatic macrophages. We anticipate that we can abrogate their local and/or distant activities by targeting gut extracellular miRNAs.